Translational strategies for optimizing musculoskeletal recovery after ACL injury

PROJECT ABSTRACT
Anterior cruciate ligament (ACL) injury is a common orthopedic injury that results in persistent quadriceps
weakness that drives poor patient outcomes and increases the risk of post-traumatic osteoarthritis (PTOA).
Despite extensive rehabilitation, and regardless of whether the ACL is surgically reconstructed, only 1 in 5
patients regain acceptable levels of quadriceps strength. As ACL injury causes an immediate shutdown of
neural signaling, neuromuscular electrical stimulation (NMES) is commonly prescribed to activate inhibited
motoneurons, thereby improving quadriceps activation and permitting strength recovery. Although NMES is
widely used, our own meta-analysis and other data show that the clinical success is inconsistent, likely due to
tremendous diversity in stimulation intensities and how soon treatments are initiated after injury. Research that
improves our understanding of the optimal intensity and timing of this treatment to maximize its effectiveness
would be immediately impactful. Our new breakthrough data highlight an important and overlooked relationship
between the loss of neural activation and mitochondrial dysfunction as important contributors to muscle deficits
after ACL injury. Neural inhibition, i.e., the loss of action potentials, disrupts post-synaptic calcium signaling
that triggers mitochondria to produce excess reactive oxygen species known to severely compromise muscle
health. These data reinforce our rationale to optimize NMES as this therapy can directly depolarize inhibited
motoneurons in the absence of volitional neural activation to maintain the electrical properties of muscle
necessary for contraction and mitochondrial health. To understand how to optimize the delivery, we developed
a non-invasive rat model that faithfully replicates the clinical injury. The objective of this proposal is to use this
preclinical model to test specific NMES treatment parameters and the underlying mechanisms of action. Aim 1
will define the intensity and time of treatment initiation that maximizes positive muscle outcomes using a
custom-built rodent dynamometer that will translate the intensity of stimulus and strength outcomes to the
human condition. Aim 2 will test the ability of optimized NMES to be protective of knee joint health by reducing
risk factors for PTOA after ACL injury. Aim 3 will determine the clinical importance between the loss of neural
activation and mitochondrial dysfunction, and explore whether future clinical applications should consider the
concurrent use of mitochondrial-targeted antioxidant therapies after ACL injury. As NMES is part of the
standard of care for ACL injury, this work will provide fundamental knowledge to guide clinical practice.

Public health relevance
PROJECT NARRATIVE Anterior cruciate ligament (ACL) injury is a common orthopedic injury that results in an immediate shutdown of neural activation to the quadriceps muscle that leads to strength deficits and drives poor patient outcomes. Neuromuscular electrical stimulation (NMES) is commonly prescribed as part of the standard of care to activate the inhibited motoneurons to promote strength recovery, however the clinical success is mixed. The goal of this proposal is to maximize the effectiveness of NMES by testing specific treatment parameters and the underlying mechanisms of action in preclinical studies to provide fundamental knowledge to guide clinical practice.